Cortical assembly formation through excitatory/inhibitory circuit plasticity

Cortical assembly formation through excitatory/inhibitory circuit plasticity.
Project Summary
Throughout the brain, sensory information is thought to be represented by the joint activity of neurons that form
functionally connected assemblies. A long-standing premise is that assemblies are formed during sensory learn-
ing by strengthening the excitatory connections between co-active neurons. However, the role of inhibition in
this process has yet to be fully elucidated. In this proposal, we will investigate the inhibitory and disinhibitory
circuits that underlie the formation, stabilization and competition between neural assemblies. However, the con-
tributions of speciﬁc interneuron classes to these processes is unknown. We have developed a theoretical model
of assembly formation that incorporates data driven inhibitory synaptic plasticity rules for Parvalbumin (PV) and
Somatostatin (SOM) expressing interneurons. Two key predictions arise from this model. First, PV interneu-
rons provide inhibition that scales with excitation to stabilize neural assemblies. And second, SOM interneurons
mediate competition between assemblies. In this proposal, we aim to experimentally test these predictions. In
the olfactory cortex, we have found that odor discrimination training promotes assembly formation in response
to rewarded odors but not unrewarded odors. In addition, we ﬁnd that inhibition scales with excitation in the
rewarded assembly. Thus, the olfactory cortex provides an ideal substrate to test predictions about the speciﬁc
roles of PV and SOM neurons in assembly competition and stabilization. In Aim 1, we investigate the role of
PV interneurons in maintaining excitation and inhibition balance and stabilizing rewarded assemblies. In
Aim 2, we investigate the role for SOM interneurons in mediating inter-assembly competition. Finally, we
have shown that a disinhibitory circuit mediated by vasoactive intestinal peptide (VIP) interneurons, gates recur-
rent excitatory plasticity onto pyramidal neurons. This suggests an intriguing hypothesis that VIP interneurons
inhibit SOM interneurons to promote the speciﬁc formation of the rewarded assembly. In Aim 3, we will use a
combined theoretical and experimental approach to investigate the role of VIP-cell mediated disinhibition
in gating assembly formation.
The studies outlined in this proposal take a comprehensive approach to investigating the synaptic and circuit
mechanisms that underlie assembly activity in the cortex. We focus on circuit motifs that are found in all cortices
and we expect our ﬁndings will have broad impact across brain areas. Our ﬁndings will illuminate the important
roles inhibitory and disinhibitory circuits play in assembly dynamics during sensory-guided behavior.

Public health relevance
Project Narrative This study investigates the circuits and synaptic mechanisms that underlie the encoding of odor information by neural assemblies within the olfactory cortex. The main goal is to understand the relationships between changes synaptic strength, the formation and stabilization of neural assemblies, odor memories and ultimately learned behavior. These studies will provide insight to the circuitry of memory formation that may be compromised in neurodegenerative disorders.